Promoting Rapid Uptake of Multilevel Latent Class Modeling via Best Practices: Investigating Heterogeneity in Daily Substance Use Patterns

PROJECT SUMMARY
Substance use among young adult college students remains a major public health concern, with recent
escalations in nonmedical Adderall use, vaping nicotine, and co-use of alcohol and cannabis. The landscape of
substance use continues to evolve, with new modes of use (e.g., vaping) and rapid legislative changes. Daily
use behaviors can take many forms, defined by number and type of substances used, mode of use, and
quantity used. Further, daily use patterns may be related to both day-level psychosocial factors (e.g., motives,
affect, stress) and person-level characteristics (e.g., sex, race/ethnicity, financial strain). Use of multiple
substances within a day (“co-use”) is increasingly prevalent and confers high risk for acute and chronic
consequences, but is insufficiently studied. The unprecedented amount of high-quality, intensive longitudinal
data (ILD) on substance use and associated risk factors holds critical information that can help explain
substance use etiology and inform the development of the next generation of interventions that are tailored to
those who need it, when they need it. However, advanced methods for analyzing ILD—including multilevel
latent class analysis (MLCA) and multilevel latent transition analysis (MLTA)—are needed to characterize the
heterogeneity of patterns of use that unfold in daily life and to identify novel day-level intervention targets.
These methods enable researchers to discover clinically relevant substance use behavior patterns and day-to-
day transitions, dynamic risk factors embedded in daily life that are associated with problematic use patterns,
and person-level characteristics that indicate for whom these risk factors are most salient. Yet MLCA and
MLTA are underused for ILD analysis, in part due to the dearth of guidance for applied researchers. Guided by
a socio-ecological framework, we will evaluate, apply, and disseminate MLCA and MLTA to analyze ILD,
considering four ways to specify models: marginal modeling, a fully parametric random effects model, a
common factor model, and a non-parametric approach for random effects. We will translate best practices for
applying MLCA (Aim 1) and MLTA (Aim 2) to ILD on substance use and co-use. We will conduct coordinated
MLCA and MLTA of daily data from two large studies of college students (3CAM: n=343, 15,798 person-days;
Project SELF: n=2068, 33,722 person-days). Empirical analyses will disentangle person-level risk factors (e.g.,
trait anxiety) and dynamic risk factors (e.g., morning affect) to isolate potential novel, dynamic intervention
targets. We will examine individual characteristics (e.g., race/ethnicity) as moderators to investigate disparities
and identify group-specific mechanisms. To maximize our overall impact (Aim 3) and ensure broad, rigorous
adoption of MLCA and MLTA, we propose a broad range of dissemination activities to include online
instructional material, a code repository, workshops, and a conference. Findings from studies using these
techniques will guide prevention scientists and clinicians in designing interventions targeting the most salient
risk factors for specific individuals at the best time for intervention.

Public health relevance
PROJECT NARRATIVE Researchers have unprecedented access to intensive data collected via smart phones and other devices; many of these datasets hold promise to reveal new information about how complex substance use behavior patterns unfold in daily life and which dynamic psychological and social characteristics confer risk for problematic use. Innovative statistical analyses of intensive data can enable prevention scientists and clinicians to design interventions that target dynamic risk factors within individuals, focusing resources on high- risk days when they are most needed. We will evaluate available approaches and compile much-needed best practices for analyzing these data, apply these approaches to diary data to characterize college students’ substance use patterns in daily life, and disseminate these approaches to facilitate broad adoption by substance use researchers nationally.